P30 Administrative Supplement to Cancer Center Support Grant to Strengthen NCI-Supported Community Outreach Capacity through Community Health Educators of the National Outreach Network.

A. ABSTRACT The National Outreach Network (NON) seeks to strengthen NCI's ability to develop and disseminate culturally appropriate, evidence-based cancer information utilizing community health educators (CHEs) embedded within cancer centers across the six NON regions. In this capacity, CHEs serve as educators and liaisons between the cancer center and medically underserved communities, ensuring that culturally and linguistically appropriate cancer resources, materials, and education are disseminated broadly. This supplement extends and supports the continuation and completion of the NCI NON-CHE Clinical Trials (CT) and Screen to Save (S2S) initiatives. This extension request sets the stage for the final close-out and sustainability activities of the S2S and CT efforts. To this end, there are two specific aims: Aim 1: To increase awareness and knowledge about CTs and the importance of participating in CTs among racially/ethnically diverse communities. Activities for the CT initiative will include group educational sessions increase awareness and knowledge about CTs and the importance of participating in CTs among 150 racially/ethnically diverse men and women ages 18 year and older. Aim 2: To increase colorectal cancer knowledge and screening rates among men and women ages 50–75 from racially and ethnically diverse communities through implementation of the NCI S2S Colorectal Cancer (CRC) program. Activities for S2S include educating 150 age-appropriate, racially/ethnically diverse men and women, to increase colorectal cancer knowledge and screening rates by referral and linkage to care. The proposed activities build on the team’s prior substantive efforts from the CNP and CNPC era (since 2005), extensive collaborations and partnerships through the institutionally supported Tampa Bay Community Cancer Network (TBCCN)- a previous CNPC, and NON-CHE activities since 2015. Activities from both efforts include virtual educational sessions and linkages to resources (CRC screening and educational materials and CT resources and educational materials). Quarterly and year-end reporting will be developed to elucidate lessons learned and best practices, and suggestions for program sustainability and expansion. A key aspect of this report will be putting into place numerous sustainability strategies and transfer relationships to ensure that cancer center outreach workers and health education specialists are trained to continue both efforts throughout the center’s 15-county catchment area.

Public health relevance
NARRATIVE The NCI National Outreach Network (NON) Community Health Educator (CHE) program spans 24 NON-sites across 6 NON regions to increase awareness amongst racially/ethnically diverse communities of colorectal cancer screening guidelines and opportunities for screening and risk reduction practices, in addition to clinical trials information, resources, and education. This project aims to strengthen NCI's ability to develop and disseminate culturally appropriate, evidence-based cancer information utilizing CHEs embedded within cancer centers to provide culturally relevant and appropriate cancer-related education to medically underserved communities. This extension request outlines specific close-out activities of the NON colorectal cancer screening and clinical trials education initiatives.